Human Laboratory Screening of Semaglutide for Alcohol Use Disorder

PROJECT SUMMARY Pharmacotherapy development remains a critical objective for reducing health and societal burdens associated with alcohol use disorder (AUD). Developing targeted treatments for specific AUD subgroups is a key aim under the NIAAA medication development strategy. Among those with AUD, cigarette smokers comprise a sizable and critical subgroup with disproportionally high long-term health risks, making it a key priority to advance therapies for concurrent AUD and cigarette smoking. Recent preclinical evidence indicates that glucagon-type peptide-1, an incretin hormone, impacts alcohol motivation and intake. So far, no studies have reported on the effects of GLP-1 receptor medications on aspects of alcohol motivation and reward in human participants. Human laboratory medication trials offer a time- and cost-effective option for validating preclinical findings prior to carrying out larger randomized controlled trials. This project will utilize human laboratory screening procedures to evaluate a GLP-1 receptor agonist as a novel candidate therapy for smokers with AUD. Participants who meet criteria for AUD and report regular light-to-moderate smoking will complete alcohol administration procedures in a within-subjects, counter-balanced design. This study will provide initial human data on the effects of a GLP-1 receptor agonist in relation to alcohol-related outcomes, including both alcohol and nicotine motivation, in participants with AUD. Validation of a candidate monotherapy for joint alcohol and nicotine reduction could have substantial public health impact.

Public health relevance
PROJECT NARRATIVE Heavy drinkers who also smoke cigarettes face significantly increased risk for cancers and other negative health outcomes, relative to those who use alcohol or cigarettes only. Among those with alcohol use disorder (AUD), smokers are recognized as an important and high-risk clinical subgroup. Presently, there are no approved medications for the joint purpose of reducing drinking and smoking. Based on evidence that glucagon-like peptide-1 (GLP-1) receptor agonists influence drug motivation and reward, this study aims to examine whether a GLP-1 agonist influences acute alcohol responses, as well as alcohol and nicotine craving, in smokers with AUD. This study will provide initial data on whether GLP-1 receptor agonists could be repurposed as joint treatments for alcohol and nicotine addiction.